MiR-152/PKM2/SLC7A5 axis in breast cancer development, chemo- and radiation-treatment response

Breast cancer (BCa) is the leading cause of women cancer mortality worldwide, and triple negative breast
cancer (TNBC) cells accounts for 15-20% BCa. However, higher therapeutic resistance and lower survival
of TNBC patients remain the major hinder of BCa treatment. Doxorubicin (Dox) and radiation are commonly
used for TNBC treatment. In our preliminary study, we found that TNBC showed much lower expression
levels of miR-152. Higher expression levels of zeste homologue 2 (EZH2) and DNA hypermethylation were
involved in miR-152 suppression in TNBC cells. To understand mechanism of miR-152 suppression, and
role and mechanism of miR-152 in regulating cancer development and Dox- and radiation-induced
resistance, we performed a lot of preliminary experiments to identify what molecules that were potential
miR-152 direct targets as well as that were upregulated in Dox-resistant TNBC or PDX tumor tissues. We
found that pyruvate kinase muscle 2 (PKM2), solute Carrier Family 7 Member 5 (SLC7A5), and
polypyrimidine tract-binding protein (PTBP1) as direct targets of miR-152 with potential ability to converse
Dox-mediated resistance. PKM2, SLC7A5 and PTBP1 levels were increased when miR-152 expression
was suppressed in TNBC cells and PDX model. We found that miR-152 suppression played an important
role in mediating TNBC metabolic reprogramming, Warburg effect switch, tumor growth and Dox resistance
through PKM2/SLC7A5/PTBP1. We showed that overexpression of miR-152 or PKM2 knockdown rendered
TNBC cells more sensitive to radiation treatment. These new findings create new opportunity to investigate
mechanism of TNBC therapeutic resistance. We hypothesize that resistance to chemotherapy and
radiation treatment, metabolic reprogramming, and TNBC development are induced by miR-152
suppression and upregulation of PKM2, SLC7A5, and PTBP1. To test this central hypothesis, we will
perform experiments through three aims. In Aim 1, we will investigate role and mechanism of miR-152
suppression in TNBC cells in doxorubicin- and radiation-induced resistance; and role and mechanism of
PKM2 switch and induction via alternative splicing by miR-152 suppression to induce Warburg effect,
therapeutic resistance, and tumor growth. In Aim 2, we will determine role and mechanism of miR-
152/SLC7A5/PTBP1 pathway in regulating metabolic reprogramming and Warburg effect switch, and in
mediating doxorubicin- and radiation-induced therapeutic resistance. In Aim 3, we will determine whether
miR-152 suppression and PKM2 induction regulate tumor angiogenesis through CXCL8 expression using a
humanized chimeric tumor model; and whether levels of miR-152, PKM2, HIF-1α, hnRNPA3, SLC7A5, and
PTBP1 are correlated each other, and are correlated with therapeutic responses and with the cancer stages
and survival. This R01 project will identify mechanisms of therapeutic resistance, and metabolic
reprogramming; and provide information for developing new treatment option of TNBC in the future.

Public health relevance
Triple negative breast cancer cells have higher therapeutic resistance and poor treatment response. This research project will study mechanism of microRNA alteration in cancer cells for inducing key protein upregulation to increase tumor growth and therapeutic resistance. The new findings will elucidate new mechanism of therapeutic resistance and identify new target(s) for improving cancer treatment option in the future.